AWI-Gen Phase 2: Genomic and environmental risk factors for cardiometabolic disease in Africans

AWI-Gen Phase 2 - Overall component
Abstract
AWI-Gen is the Africa Wits-INDEPTH partnership for Genomic Studies, a NIH funded and university
supported Collaborative Center of the Human Heredity and Health in Africa (H3Africa) Consortium. It is a
strategic partnership between the University of the Witwatersrand, Johannesburg (Wits), and the International
Network for the Demographic Evaluation of Populations and Their Health (INDEPTH). AWI-Gen examines
genomic and environmental factors that interact with individual physiology and behaviors to influence
body composition, body fat distribution and cardiometabolic disease and risk in African populations,
with the aim to provide insights and evidence toward effective prevention, treatment and intervention strategies.
Empirical, validated African data to inform modeling, projections and policy remain scant and widening health
inequalities are evident within and between countries, despite global improvements in age-standardized mortality
and morbidity. AWI-Gen Phase 1 is a population-based cross-sectional study with a research platform of over
12,045 participants 40-60 years from Burkina Faso, Ghana, Kenya and South Africa that addresses these
disparities. Our four-year partnership has successfully generated epi-demographic, environmental, health
history, behavioral, anthropometric, physiological and genetic data across a range of rapidly transitioning African
settings.
The AWI-Gen Collaborative Center provides a unique resource to examine genetic associations and gene-
environment interactions that will contribute to Afrocentric risk prediction models and African-appropriate
Mendelian Randomization instruments, and exploit their potential to improve personal and population
health – while strengthening regional research capacity.
Our overall goal is to establish the genomic contribution to cardiometabolic disease and risk at a time
when multiple interacting transitions, in the presence of high background HIV or malaria prevalence, are
driving a rapid escalation in CMD across the African continent. To deepen our understanding of CMD and
risk in African populations, we aim to extend data collection and develop a population-based `super' cohort (from
harmonized cohorts across geographic settings) that is well-suited to examining progression among middle-aged
and older persons. We have developed four closely linked research projects: (1) Genetic association studies to
elucidate functional pathways involved in determining body composition and risk for CMD by detecting pivotal
genomic and environmental contributors. (2) Building an analytic resource of bioinformatics analysis tools
appropriate for African populations, including genetic risk determination, Mendelian Randomization instruments
and gene-environment interaction algorithms. (3) Examining changes over the menopausal transition in body
composition and CMD risk factors, and evaluating the resulting risk from physiological, genetic and epigenetic
perspectives. (4) Examining the microbiome in older adults and its relationship to obesity, diabetes and glucose
tolerance, and CMD risks arising from the menopausal transition.
We hypothesize that there are African-specific gene-environment interactions that are key drivers of the
health transitions unfolding across the continent, and that environmentally influenced epigenetic and
microbiome changes play an important role. HIV and malaria will be considered in our models as they may
have critical influences. Our emphasis on women in AWI-Gen Phase 2 is informed by the increasing prevalence
of obesity and associated morbidities in women, especially in regions farther along an epidemiological transition
path. Genomic research in Africa has the unique potential to harness the lower levels of linkage disequilibrium
in African genomes for fine mapping of associated loci to identify causal genes and variants, and guide functional
analysis in candidate regions. Our first project provides the foundation for the development of cohorts in west-
east-south Africa to examine the distinct and interacting influences of genetic variation, environmental, social
and demographic factors, personal behaviors, and proximal risk factors on body composition and susceptibility
to CMD. This will be the first multi-ethnic study in sub-Saharan Africa to address a critical shortfall in
understanding at a time when the force of transitions is driving the rise in cardiometabolic conditions.
We expect findings to be highly relevant in our continental context and to contribute insights far more
widely.